Neural circuits of vocal communication during social bonding

PROJECT SUMMARY
Vocal communication is a fundamental behavior that humans and many other mammals use to cultivate social
attachments. These social attachments are needed to protect against perceived loneliness, which is associated
with an increased risk of mental disorders and physical disease. The long term goal of this research proposal is
to uncover the unique role of vocal communication in building and maintaining social attachments, and to identify
the neural circuits that link vocalization to bonding. Our laboratory has used whole-brain imaging of immediate-
early gene (IEG) activity to map the neural systems active during pair-bonding in the monogamous prairie vole.
This research implicates the medial prefrontal cortex (prelimbic, infralimbic, and anterior cingulate areas) as a
key hub within the pair-bonding network. My work also shows that prairie voles are incredibly vocal throughout
pair-bonding, with vocalization associated with affiliative interactions like courtship and proximity maintenance.
We also find that vocalization rates are correlated with prefrontal IEG expression during bond formation. The
proposed experiments will test the central hypothesis that prefrontal cortical regions modulate vocalizations that
promote pair-bonding. The goal of the K99 phase research is to develop a foundational understanding of how
vocal communication is involved in the pair-bonding process. In Aim 1, I will determine how inhibition of vocal
production impacts affiliative interactions and whole-brain IEG induction during bond formation and maintenance.
In the process, I will learn the systems neuroscience methods of iDISCO, light-sheet microscopy, and related
analysis pipelines. In Aim 2a, I will map the prairie vole vocal circuit using trans-synaptic tracing and whole-brain
imaging to determine where vocalization and bonding circuits overlap. This will deepen my training with whole-
brain imaging and mammalian neuroanatomy, as well as train me in the viral mapping of neural circuits. To
advance my managerial skills, my K99 training will also include formal, targeted training in leadership, project
management, and mentorship, overseen by a diverse advisory committee. In the R00 phase, my research will
test whether prefrontal regions promote vocalization during pair-bonding. In Aim 2b, I will map afferent and
efferent projections of prefrontal regions to identify anatomical connections between the vocal and bonding
circuits. In Aim 3, I will manipulate the anterior cingulate cortex and its descending projections to examine its
influences on vocalization, bond formation, and bond maintenance. This research will provide insight on the
neural substrates that link vocal behavior to social attachment. The training will allow me to build on my unique
ethological background in animal vocalization with the modern tools of behavioral and systems neuroscience.
The combined elements of this research proposal will lay a foundation for an independent career investigating
the neural mechanisms through which communication supports healthy social connection.

Public health relevance
PROJECT NARRATIVE Loneliness is an emotionally taxing state that is a strong risk factor for mental illness, physical disease and early mortality, and yet the neural mechanisms that facilitate social connection remain relatively unknown. Non-verbal vocalization is a major means of maintaining social bonds in many species, including humans. The proposed research will use cutting-edge whole-brain methods and behavioral analyses to elucidate the neural circuits that relate vocalization to bonding in the monogamous prairie vole, a major model of social attachment.